IMPACT Project 4 – Budget impact, cost-effectiveness, and population outcomes of interventions to improve HPV vaccine communication and uptake in rural and nonrural communities

ABSTRACT – Project 4
Human papillomavirus (HPV) cancers are preventable through vaccination. Yet HPV vaccine coverage is
well below the national goal of 80%, especially in rural areas where HPV cancers are more common. HPV
vaccine communication interventions are a promising approach to address low uptake. As part of the P01
Program Project, “Improving Provider Announcement Communication Training (IMPACT),” Projects 1-3 will
test novel enhancements of the Announcement Approach Training (AAT) intervention in healthcare systems to
improve primary care team members' HPV vaccine communication. The overall objective of Project 4 is to
facilitate decision makers' selection and adoption of AAT and other effective HPV vaccination
interventions, by quantifying tradeoffs in their comparative cost and health impact in rural and nonrural areas.
Aim 1 is to identify differences in contextual factors in rural and nonrural clinical settings that may
influence the implementation and effectiveness of enhanced AAT interventions. Using a mixed-methods
approach, we will conduct semi-structured interviews in rural (n=20) and nonrural areas (n=20) among primary
care team members, quality improvement decision makers, and health administrators, as well as survey a
national sample of primary care team members (n=2,500) to examine contextual differences across rural and
nonrural clinical settings. Aim 2 is to evaluate the budget impact, cost-effectiveness, and population
outcomes of HPV vaccine communication and other evidence-based interventions in rural and nonrural
clinical settings, including the enhanced AAT interventions studied in Projects 1-3, to facilitate comparisons for
decision making. We will develop a national county-specific HPV microsimulation model that overlays
interventions onto populations reflecting patterns of baseline HPV vaccination, HPV transmission, and
progression to HPV cancers to project the anticipated budget impact, cost-effectiveness, and population
outcomes of HPV vaccine interventions in rural and nonrural clinical settings. Aim 3 is to aid stakeholder
implementation planning by developing a web-based interactive decision support tool illustrating the
value and implementation outcomes of HPV vaccine interventions in rural and nonrural clinical settings. We will
engage stakeholders to evaluate the usability of the decision support tool for decision making and add to the
AAT Intervention Package. Project 4 addresses the IMPACT Program Project theme of amplifying HPV
vaccine communication interventions' impact in healthcare systems. Our project findings will translate the
health impact and cost of interventions tested in Projects 1-3 in rural and nonrural areas into a dissemination
format well-suited to the needs of decision makers in healthcare systems to accelerate the adoption of
promising HPV vaccine communication interventions to prevent cancer in diverse geographic contexts.

Public health relevance
NARRATIVE – Project 4 Our goal is to facilitate the adoption of promising HPV vaccine communication interventions. This study will examine the budget impact, cost-effectiveness, and population outcomes of HPV vaccine communication interventions in rural and nonrural communities, and aid decision makers with a decision support tool. We expect generated evidence to accelerate the uptake of promising interventions to improve HPV vaccination.